Probing the cardioprotective effects of sulfane sulfurs with next generation fluorescent sensors

Project Summary
Redox imbalances of reactive sulfur species (RSS) in cardiac cells contribute to
cardiovascular diseases such as myocardial ischemia-reperfusion (MI/R) injury and heart failure.
Applications of sulfane sulfurs have been found to cause cardioprotective effects, and sulfane
sulfur bioavailability in plasma has even been recently suggested to be a biomarker for
cardiovascular disease (CVD). However, this field currently lacks clear understandings as to how
endogenous RSS, particularly sulfane sulfurs, work. Our long-term goal is to elucidate the
complex sulfane sulfur pathways at various health stages of cardiac cells and use this information
to drive the development of early diagnostic tools and therapies for CVD. Specifically, this project
will meet the critical need of having effective methods to study these pathways by developing
chemical tools that: 1) quantifiably ‘see into cells/tissues’ despite the presence of biological fluids
such as blood and 2) turn-on only after subcellular localization. These highly sensitive, specific,
and targetable/triggerable next generation fluorescent sensors will allow us to probe the
cardioprotective roles of sulfane sulfurs in cardiac cell models of MI/R injury even to subcellular
extents and non-invasively decipher complex cardiovascular sulfur-mediated redox pathways. We
expect that: 1) promising sensors will be identified for future evaluations in animal models of MI/R
and 2) our tools and studies will establish a strong basis for advancing the clinical potential of
sulfane sulfurs through a greater understanding of the mechanisms by which sulfane sulfurs
regulate redox environments in CVD. The long-term goal for this fellowship award is to develop
essential skills for a successful career as a chemical biology professor studying human diseases
at an R1 institution. A team consisting of the sponsor and collaborators has been assembled with
expertise in organic chemistry and synthesis, redox biology, chemical biology, molecular and cell
biology, computational/data sciences, and cardiovascular diseases. Further training will be
obtained from conference attendance and presentations in conjunction with teaching certificate
programs, outreach, and leadership positions at Brown University.

Public health relevance
Project Narrative While sulfane sulfurs have been found to combat myocardial ischemia-reperfusion (MI/R) injury and heart failure, several essential questions about these small signaling molecules must be addressed to advance our understanding of their biological mechanisms and clinical potentials. In this project, we plan to develop a chemical toolbox of next generation fluorescent sensors for sulfane sulfurs and use them to probe how sulfane sulfurs protect cardiac cells under the development of disease. We believe these studies will establish a strong basis for the development of early diagnostic tools and therapeutics for cardiovascular disease by providing crucial, yet accessible tools needed to decipher the complex redox environments in the cardiovascular system and by deepening our knowledge of the roles of sulfane sulfurs at the cellular and subcellular levels.